The Efficacy of Pranayama in COPD

DESCRIPTION (provided by applicant): Chronic obstructive pulmonary disease (COPD) is a major health problem worldwide, and is currently the third leading cause of death in the United Sates. Patients with COPD mainly complain of shortness of breath with daily activities and exercise. A key mechanism of dyspnea is dynamic hyperinflation, or air trapping, which results from the severe airflow limitation that characterizes the disease. Inhaled bronchodilators and corticosteroids may help, but these therapies are expensive and may have side effects. Pulmonary rehabilitation is very effective at reducing dyspnea and improving exercise tolerance, but it is not widely available to patients. We propose studying the effect of a simple breathing exercise known as pranayama, or yogic breathing. Our hypothesis is that the practice of pranayama will improve exercise tolerance in patients with COPD. We believe that the mechanisms involved will include reduced dynamic hyperinflation as well as beneficial effects on lung mechanics, inflammation and oxidative stress. This hypothesis will be tested in a randomized, double blind, controlled trial of pranayama vs. usual care (education) in COPD patients. In Specific Aim 1, we will determine the effect of pranayama on exercise tolerance as measured by 6 min walk distance; in Specific Aim 2, we will determine the effect of pranayama on dynamic hyperinflation as measured by changes in inspiratory capacity before and after exercise; and in Specific Aim 3, we will determine the effect of pranayama on oxidative stress (exhaled breath H202, 8-isoprostane, glutathione), systemic inflammation (serum c-reactive protein, interleukin-6, glutathione and red cell distribution width), dyspnea level (Borg scale, MRC scale, BDI/TDI, CRQ), the BODE index, and quality of life (St. George Respiratory Questionnaire). The study is designed to be applicable to a wide variety of clinical settings, since it will involve two diverse clinical sites (Burlington, VT and Houston, TX), require minimal direct intervention, and engage participants in self- learning and practice. The data from this study will provide fundamental new insights into the mechanisms of action of pranayama, and will be critical in designing a large, multicenter trial to test the effectiveness of pranayama in patients with COPD. PUBLIC HEALTH RELEVANCE: Chronic obstructive pulmonary disease (COPD) is a major health problem worldwide, and patients mainly suffer from severe shortness of breath with exercise. This study will investigate the effects of the practice of the yogic breathing method pranayama on exercise tolerance in patients with COPD. This intervention may prove to be an important adjunct to COPD therapy, since it is simple, inexpensive, and widely available. (End of Abstract)

Public health relevance
Chronic obstructive pulmonary disease (COPD) is a major health problem worldwide, and patients mainly suffer from severe shortness of breath with exercise. This study will investigate the effects of the practice of the yogic breathing method pranayama on exercise tolerance in patients with COPD. This intervention may prove to be an important adjunct to COPD therapy, since it is simple, inexpensive, and widely available. (End of Abstract)